COMPARATIVE TRIAL OF TWO DOSES OF DDI IN SYMPTOMATIC HIV INFECTED CHILDREN

A study to evaluate the efficacy, safety and tolerance of two dose levels of dideoxyinosine in HIV infected children who are either unresponsive to zidovudine or intolerant to zidovudine.